Enhanced Identification of Ocular Phenotypes and Outcomes in Electronic Health Record Data

ABSTRACT
The transition from paper charts to electronic health records (EHRs), advances in computing
power and storage capacity, and the availability and accessibility of sophisticated machine
learning algorithms have revolutionized the ability for researchers to tap into Big Data and make
use of it to answer all sorts of important clinical questions. However, maximizing the utility of all
of this rich clinical data from EHRs and clinical registries is predicated on the ability for researchers
to accurately identify which patients have specific diseases; to accurately classify conditions
based on their disease severity; to ascertain which patients are improving, stable, or deteriorating;
and to appropriately identify and quantify clinically relevant outcomes. Currently, nearly all
researchers who work with Big Data in ophthalmology rely exclusively on administrative billing
codes to identify common ocular diseases and outcomes of interest. Yet, research has shown
that sole reliance on billing codes is fraught with limitations and does not take full advantage of
the plethora of useful information routinely captured in structured and free-text EHR data. In this
proposal we develop, rigorously test, and validate an innovative approach to permit researchers
to more accurately identify and classify patients with common sight-threatening ocular diseases
and capture transitions from less to more severe disease states and key outcomes of interest.
Based on preliminary studies we performed, we believe our approach to enhanced ocular
phenotype identification is substantially more accurate than exclusive reliance on billing codes. In
Aim 1, we use this approach to EHR data to identify and categorize patients with 3 of the most
common causes of irreversible vision loss—glaucoma, diabetic retinopathy, and macular
degeneration. In Aim 2, we extend enhanced phenotype identification by trying to identify novel
forms of these 3 conditions; we will use cluster analysis to identify groups of clinical features
associated with these 3 ocular diseases that co-segregate together. We will also test whether
some of these clusters are associated with better or worse clinical outcomes. In Aim 3, we apply
our approach to identify key ocular outcomes in EHR data such as disease stability and
progression from less to more advanced stages for each of the 3 ocular diseases of interest. By
fulfilling the aims of this proposal, we will permit researchers throughout the country and the world
to more accurately identify important ocular diseases and outcomes in EHR and clinical registry
datasets. This will serve as a key building block to permit researchers to incorporate Big Data into
machine learning and artificial intelligence applications, genotype-phenotype association studies,
patient recruitment for clinical trials, and many other clinical and translational research projects.

Public health relevance
NARRATIVE For researchers to take full advantage of the large amount of clinical data that is captured in electronic health records and incorporate this information into machine learning and artificial intelligence applications, outcomes research, genotype-phenotype association studies, and other areas, it is critically important to be able to accurately identify diseases and outcomes of interest; the existing approach relies exclusively on administrative billing codes to identify these entities. In this study we will develop and test novel approaches to identifying and characterizing sight-threatening eye diseases and their outcomes in electronic health record data. By fulfilling the aims of this grant, we will make it easier for researchers throughout the country and the world to make use of electronic health record and clinical registry data to study patients with chronic diseases, which is essential to the mission of the National Institutes of Health.